Developing a drug-inducible gene therapy for temporal lobe epilepsy

There are 3 million Americans with epilepsy. This research aims to develop a first-in-class drug-
inducible gene therapy for the most common form of focal epilepsy, temporal lobe epilepsy (TLE). TLE
affects half a million Americans, yet despite the size of this problem, medical treatment of TLE fails in
a third of these patients. Clearly there is a large unmet clinical need for a treatment without side effects.
The guiding hypothesis of these studies is that TLE is a circuit-based disease, requiring the
development of next-generation gene therapies that target these circuits. Key technological advances
made to address this hypothesis include: 1) development of novel animal models of TLE with
spontaneous seizure characteristics that are amenable to drug screening; 2) mapping epileptic circuits
using activity-dependent promoters; and 3) development of drug-inducible gene therapies that target
specific circuits. It was discovered that electrical stimulation of a specific strain of mouse (VGAT-Cre)
was sufficient to trigger limbic epilepsy. To extend the model to other strains of mice, electrical
stimulation was combined with a chemoconvulsant, kainic acid. This hybrid approach effectively
triggered spontaneous seizures in commonly used mouse strains, such as C57Bl/6. Importantly, the
hybrid approach opened the door for studies using the TRAP2 strain, which has proven useful for circuit
mapping studies. The drug-inducible gene therapy uses the well-established doxycycline (Dox)
regulated system. The technological challenges were to miniaturize this system so it fits in viral vectors,
reduce gene expression in the absence of the inducer (leak), and develop a toolkit of promoters to
target neuronal subtypes. The goal is to develop a Dox-On system where Dox administration reduces
seizures and that possible side effects can be reduced by lowering the Dox dose. Reducing leak to
background levels is an important safety feature that has yet to be incorporated in any FDA-approved
gene therapy. The mechanisms of action of many current antiseizure drugs are to either reduce the
activity of excitatory neurons or enhance the activity of inhibitory neurons. By developing gene
therapies that selectively target these types of neurons, the proposed studies will compare these two
approaches. Key metrics for these therapies are to show they reduce spontaneous seizure frequency
by 50% and target specific nodes in the epileptic circuit. Efficacy studies will use rigorous preclinical
study designs with blinding, reproducibility, and target engagement. Contributing to the success of this
study is a rich environment for clinical translation of basic research in animal models of epilepsy.

Public health relevance
Project Narrative Temporal lobe epilepsy (TLE) is debilitating disorder that affects millions of people worldwide and is difficult to treat with medicines. This grant will combine mapping of epileptic neuronal circuits with novel gene therapy approaches to inform CNS circuit therapies for epilepsy.